PaRtnEring to build understanding oF gEnomics Responsibly: the PREFER Community Health Worker Genomics Research Education Program

Recent trends highlight the importance of championing a genomics research workforce that is well-prepared to support genomics research. Offering training to the entry-level workforce such as Community Health Workers (CHWs) can support genomics research more broadly by ensuring the entry-level workforce fully understands the genomics aspects of the research in which they are engaged. The CHW workforce has witnessed unprecedented growth, with an anticipated 15% increase in the number of CHWs in the US by 2029. Although CHWs are familiar with the communities they serve, regularly interact with a broad range of populations, and have expressed interest in receiving training in genomics and related competencies, CHWs have yet to be provided with appropriate training in genomics. Thus, CHWs are an obvious but not well-equipped potential entry-level genomics research workforce. To address the unmet need of developing a trained network of CHWs with genomics competencies, we propose the PaRtnEring to build understanding oF gEnomics Responsibly (PREFER) CHW Genomics Research Education Program (PREFER CHW). Through this program we will work closely with five partner sites in the Southeast United States (The Center for Community Health Alignment, North Carolina CHW Association, South Carolina State University, Southern Mississippi University, and the Tennessee CHW Association). The CHW workforce is highly active in the Southeast, with over 10,000 CHWs engaged in the region and over 3,000 CHWs in the four states (South Carolina, North Carolina, Mississippi, and Tennessee) that are participating in PREFER CHW. Specifically, we will: 1) refine and finalize an educational curriculum (PREFER CHW) focused on 10 key genomic competencies, 2) implement the program among 150 CHWs using online asynchronous and synchronous methods, 3) equip partner sites to continue delivering PREFER CHW, and 4) assess the content and program goals of PREFER CHW. Our approach builds from the substantial strengths of the lead site faculty (Wake Forest University Health Sciences) in genomics education and history of collaboration with partner sites. PREFER CHW offers a viable, sustainable solution of training CHWs in genomics competencies to help enhance the capacity of the entry-level genomics research workforce and leverages the existing network of CHWs to improve engagement in genomics research.

Public health relevance
The PaRtnEring to build understanding oF gEnomics Responsibly Community Health Worker (PREFER CHW) genomics research education program is a first-of-its-kind training focused on building CHW competencies in genomics to support an entry-level genomics research workforce and increase participation in genomics research. In partnership with five sites in the Southeast United States we will develop, deliver, and evaluate PREFER CHW. At the conclusion of the program, we will have trained a cohort of 150 CHWs across four states and equipped partner site faculty to continue delivering PREFER CHW in the future.